Elucidating the dynamical and structural molecular factors at the origin of non-enzymatic protein-protein and protein-DNA cross-links

Project Summary
Non-enzymatic protein-protein and protein-DNA cross-links are deleterious post-translational
modifications that have been associated with many severe pathologies, including cancer metasta-
sis, retinopathy, chronic renal failure, skin and bone disorders, aging, diabetes, Alzheimer’s, Par-
kinson’s and cardiovascular diseases. However, the development of therapeutic strategies is hin-
dered by our poor understanding of their formation. We propose to address this gap in knowledge
using computational methods based on intrinsic electric field calculations. Our goal is to identify
the structural and dynamical molecular factors at the origin of the formation of non-enzymatic
protein-protein and protein-DNA cross-links. We focus our study on sugar-mediated cross-links,
initiated by glycation reactions, as it has been shown to occur in a broad range of systems.
We hypothesize that partial depletion of the protein (or DNA) hydration layer exposes side
chains (or nucleobases) to surrounding carbohydrates. This facilitates glycation reactions whereby
reducing sugars (glucose) react with the free amine groups. Glycated proteins and DNA then
have enhanced ability to form adducts, altering their biofunction. Our proposed research seeks
to provide a molecular interpretation of sugar-mediated cross-link formation and can be divided
into three thrusts ; each of which with the potential to expand into a standalone research direction.
First, we propose to characterize the density of the hydration layer of healthy and pathological
proteins and DNA strands known to aggregate (collagen, elastin and α-synuclein) at the quan-
tum level. Our preliminary data on mineralized collagen systems show that water adsorption is
controlled by the nature of the environment rather than the nature of the adsorption site, consistent
with experimental observations. This suggests that the density functional theory protocol we de-
veloped for this study is suitable for the characterization of macromolecule-water interactions.
Second, we propose to model carbohydrate reactivity in dehydrated and hydrated biomole-
cules, as a proxy for non-enzymatic glycation reactions. The novelty of our approach is to intro-
duce accurate reactivity information in classical molecular dynamics simulations using intrinsic
electric fields as a metric for bond formation. Our preliminary data verify the feasibility of such
study and include the development of an open-source code that allows this type of calculations.
Finally, we propose to integrate our atomistic data into a microscopic kinetic model of protein-
protein and protein-DNA cross-linking processes. With this model, we aim to predict the critical
density, location, cooperativity and strength of cross-links that are associated with known patho-
logies, paving the way towards the identification of therapeutic points of intervention.

Public health relevance
Project Narrative The proposed research aims to deepen our understanding of sugar-mediated protein-protein and protein-DNA non-enzymatic cross-link formation. We propose to identify the structural and dynamical molecular factors responsible for these abnormal cross-links in biological tissues. Our theoretical approach complements existing observations by accessing time and length scales invi- sible to experiments. Because cross-links are involved in a broad range of diseases, from cancer metastasis to bone and skin disorders, this project will lay the foundation for advances in disease treatment or prevention, ﬁtting NIGMS's mission statement.